Cancer Center Support (Core) Grant

DESCRIPTION (provided by applicant): The research of the MIT Center for Cancer Research (CCR) faculty is focused on elucidating the basic mechanisms of cancer development. It is organized into three distinct programs organized around shared common interests and overlapping long-term goals. These are Program 1: Molecular Genetics and Immunology;Program 2: Genetics and Model Systems;Program 3: Cell Biology. As an NCI-designated basic research center, the CCR is both a physical entity and an organizing body for MIT's cancer research community at large. Of the thirty member laboratories, eleven are located in the Center's home building (E 17/18), the others are located in the Koch Biology Building (4), the Broad Institute (2), Whitehead Institute (7), the Division of Biological Engineering (4), and the Department of Chemistry (1) and the Department of Chemical Engineering (1). The Center functions to facilitate interactions among the member laboratories, foster research collaborations, provide integral core facilities as well as seed funding for cancer research. The Center operates or shares in support of eleven core facilities that provide access for member laboratories to critical research technologies, materials, infrastructure and trained personnel. It also trains a large number of graduate students, postdoctoral fellows, clinical fellows and undergraduate students in basic cancer research.